An Investigation of Vitamin A Palmitate Supplementation in Patients withAMD and/or Reticular Pseudodrusen (RPD) and Delayed Dark Adaptation

Objective: The objective of this study is to investigate the potential efficacy of vitamin A palmitate
in improving dark adaptation in participants with reticular pseudodrusen (RPD) and abnormal dark
adaptation.
Study Population: Ten participants will be initially accrued, however, up to twenty participants
with RPD who meet the eligibility criteria may be enrolled. In the event that a participant
withdraws from the study prior to receiving two months of study supplementation for a reason
unrelated to an adverse reaction, an additional participant will be accrued. A maximum of ten
additional participants may be accrued in order to obtain ten participants for the primary outcome
analysis.
Design: This is a pilot, uncontrolled, prospective, single center study to investigate the potential
efficacy of vitamin A palmitate in improving dark adaptation in participants with AMD and
abnormal dark adaptation.
Outcome Measures: The primary outcome is the measurement of dark adaptation parameters
(thresholds and kinetics) by the following: dark adaptation times as measured by the AdaptDx
comparing before and after vitamin A palmitate and dark adaptation parameters as measured by
the Medmont comparing before and after vitamin A palmitate supplementation. The secondary
outcomes are changes in low luminance visual acuity (LLVA) and changes in patient reported
outcomes as measured by the low luminance questionnaire (LLQ).